Surgical Scientist Training Grant in Health Services and Translational Research

Abstract: The enduring goal of this T32 application is to support the continued training of surgical
residents to become consequential physician-scientists in Health Services and Translational
Research. In our well-funded laboratories, the translational research training of surgical scientists will
focus on the fields of trauma, burn, wound healing, and regenerative medicine while the health
services research training will be targeted in the critical discipline of clinical outcomes investigation in
order to educate surgeons and to promote evidenced-based medicine. The former emphasizes
translating scientific discoveries from the research bench to the patient’s bedside, whereas the latter
centers on determining the efficacy of therapeutic interventions to improve clinical outcomes. The
purpose of the health services research portion of the training grant is for young surgeons to integrate
clinical experience with training in program development and research methods. The purpose of the
translational scientific portion of the training grant is to provide formal instruction on laboratory
research project design and sound research methods of hypothesis-driven investigation to push the
boundaries of surgical innovation. The curriculum is designed to encourage the participants of the
program to become future academic surgical investigators who will apply this training to find solutions
to the many challenges posed by the U.S. healthcare system. The program will foster a cadre of well-
prepared surgical scientist trainees to ease their transition into academics. Future academic surgical
investigators will benefit from greater knowledge in both important areas as they will be in the unique
position to initiate research that bridges clinical and basic experimentation while also evaluating the
effectiveness of their treatments. Our past trainees have successfully launched careers in academics
and received PhDs using our T-32 grant training as a career defining experience. This newly
structured organization that was initiated as an innovative iteration of this training grant in our last
grant cycle has demonstrated great success over the past 5 years. Building upon the distinguished
achievements of the longstanding history of our T-32 training program at this institution, this novel
programmatic adaptation is particularly well suited toward training the academic surgeons of the 21st
century.

Public health relevance
Project Narrative: This training grant brings together a successful and expert group of dedicated research investigators who will combine their efforts at a renowned university to train outstanding and promising surgical residents to develop new treatments to enhance healing and to determine the successful delivery of surgical care. Our aim is to address the fundamental need to train American surgical investigators to develop the skills in translational scientific inquiry and to learn and apply the key principles of health services research in order to foster the discovery of new therapies to treat patients with wounds as well as congenital and acquired deformities and to determine the efficacy of those treatments.